High Throughput Next Generation Sequencing, Single-Cell Omics and Spatial Transcriptomic: supports genomics and epigenomics research in muscle, skin, bone and autoimmune diseases

The Genome Technology Section has been actively involved in a large number of NIAMS published projects, including the following:

- Psat1-generated alpha-ketoglutarate and glutamine promote muscle stem cell activation and regeneration

- Genetic Risk Factors for Early-Onset Merkel Cell Carcinoma.

- Study of chromatin landscape and regulatory networks governing murine epidermal differentiation

- Study on the role of pathogenic autoantibody internalization in myositis.

- Study of somatic mutations in UBA1 and severe adult-onset Autoinflammatory Disease.

- Identification of Unique microRNA Profiles in Different Types of Idiopathic Inflammatory Myopathy

- Inpact of transcriptional derepression of CHD4/NuRD-regulated genes in the muscle of patients with dermatomyositis and anti-Mi2 autoantibodies

- Role of Polycomb Ezh1 inmantaining murine muscle stem cell quiescence through non-canonical regulation of Notch signaling.

- Transcriptomics, regulatory syntax, and enhancer identification in mesoderm-induced ESCs at single-cell resolution

- Transcriptomic profiling study on subsets of immune checkpoint inhibitor involved in myositis.

- Specification and maintenance of cell lineages in the skin, and study of the regulation of stem cells in the skin.

- Integrating single-cell transcriptomes, chromatin accessibility, and multiomics analysis of mesoderm-induced embryonic stem cells.

- Discovering the molecular mechanisms regulating metabolism and epigenetics during specification, differentiation, and regeneration of skeletal muscle cells.

- Transcriptomic, epigenetic, and functional analyses implicate neutrophil diversity in the pathogenesis of systemic lupus erythematosus.